Multimodality Radiological Image Processing System

During this year, data from the MRIPS Archive and Retrieval System (MARS) is being migrated over to the Clinical Centers new PACS (Picture Archiving and Communication System). A new version of MEDx 3.4.1 was released this year. Enhancements to MEDx include a DICOM PET reader and a new DICOM image manager. The perfusion module has also been improved and now allows users to manually specify arterial pixels.